Stress Phenotypes and Preterm Birth: Immune and Energetic Cellular Dysregulation and the Preventive Effect of Social Support

PROJECT ABSTRACT
At odds with common assumptions — and hope, pregnancy ends in preterm birth (PTB) for approximately 1 in
10 women. Yearly PTB affects 15 million infants worldwide and 386,580 in the United States. PTB is the leading
cause of global, and U.S., neonatal mortality and morbidity and is associated with future risk for poor physical
(higher blood pressure, chronic kidney disease, wheeze/asthma) and mental (ADHD, IQ decrements) health.
Maternal health is not spared: women who deliver preterm are at an increased risk for depression, hypertension,
cardiovascular and renal disease later in life. In the U.S., the racial and ethnic disparities in PTB rates are
dramatic and independent of socio-economic status (SES): overall, 14.12% for Non-Hispanic Black compared
to 9.09% for Non-Hispanic White women. Psychosocial stress and childhood trauma each are associated with
risk for PTB. PTB has an intergenerational impact: mothers born preterm are more likely to give birth pretern,
especially amongst Black women. Biomarkers to predict PTB have proven unsuccessful, and do not account for
this emerging recognition of intergenerational transmission of PTB risk specifically via maternal heritage.
Mitochondria, which contain their own genome, the mitochondria DNA, are inherited from the mother and
represent a potential intersection point between psychosocial experiences and their biological embedding,
including via immune dysregulation, in underlying disease outcomes. We aim to apply a mitochondria
psychobiology approach to delineate by which mechanisms life stress — including discrimination and childhood
trauma — results in disproportionate risk of PTB in minority women, and evaluate mitochondria as potential
biomarkers of this birth outcome. In a sample of post-attrition n=175 pregnant women we will test the following
three aims: Aim 1: To determine whether a data driven approach to multiple, 1st trimester psychosocial (self-
report stress discrimination, 24-hour ambulatory mood, social support), lifecourse (hair cortisol, childhood
trauma), and biological variables (acute laboratory physiological stress reactivity) generate unique stress profiles
that partially explain the racial/ethnic differences in gestational age at birth. Aim 2: To identify molecular indices
of mitochondrial and immune functioning in the mother (3x blood draw), placenta, and fetal cord blood that
mediate the association between 1st trimester maternal stress phenotypes and risk for earlier gestational age at
birth. Aim 3: To evaluate if reduction in stress levels and/or improvement in social support over the course of
pregnancy is associated with molecular indices of mitochondrial and immune functioning and (exploratory)
reduced risk of earlier birth relative to national and hospital norms. This new conceptual framing of this adverse
health outcome (1) incorporates evidence of the psychosocial factors contributing to risk, (2) aims to account for
the racial/ethnic disparities, and (3) harnesses cutting-edge mitochondria knowledge and tools to better
characterize PTB’s pathophysiology and identify novel targets for its intervention and prevention.

Public health relevance
PROJECT NARRATIVE Pregnancy ends in preterm birth (PTB) for approximately 1 in 10 women, though more often for Non-Hispanic Black women, 14.12% PTB rate, compared to 9.09% for Non-Hispanic White women. Psychosocial stress and childhood trauma each are associated with risk for PTB and PTB has an intergenerational impact: mothers born preterm are more likely to give birth pretern, especially amongst Black women. In this project, we will study mitochondria, which contain their own genome, the mitochondria DNA, and are inherited from the mother, as they represent a potential intersection point between psychosocial experiences and their biological embedding in underlying disease outcomes such as PTB